Rapid, Automatic, AI Driven, Aortic Valve Measurement Software

Project Summary
While trans-catheter aortic valve replacements (TAVR) has revolutionized valve replacement, planning for this
procedure using CT imaging is a time-consuming manual process requiring hours of advanced cardiac imager’s
time. Furthermore, many centers in the United States turn over the job of measurements to in-experienced sales
reps who are more focused on the interests of the valve manufacturers they represent without any formal training
or knowledge in cardiac anatomy or physiology. DASI Simulations LLC has developed an innovative cloud-based
artificial intelligence (AI) platform that promises to automatically perform these complex measurements in a
matter of few minutes. The measurements are performed based on AI-predicted landmarks using a pipeline of
convolutional neural networks with advanced image sampling techniques. As preliminary work we have already
established the product feasibility and have our regulatory approach vetted through the FDA with a successful
presubmission completed. In this SBIR Phase 1, we propose a non-hypothesis driven approach with two specific
aims to execute on FDA recommendations to finish the verification and validation activities, namely: (1) Develop
and validate the DASI Dimensions measurement module to extract TAVR pre-planning procedural
measurements; and (2) prepare and submit document package for Food and Drug Administration (FDA) 510k
clearance. Because our technology differentiates itself from our competitors who use traditional expensive
manual measurement approaches, we are posed to make a significant positive and disruptive impact in how
structural heart therapy is planned in the clinic with potentially substantial clinical impact in terms of patient
outcomes and hospital efficiency.

Public health relevance
PROJECT NARRATIVE The current process physicians must undergo to obtain pre-procedural planning measurements before transcatheter aortic valve replacement (TAVR) is very time-consuming and subject to high variability between physicians and manual error. Additionally, the burden of taking these measurements is often given to industry representatives who only measure for the valve manufactured by the device company they represent. The software developed in this grant proposal uses artificial intelligence to automatically complete patient-specific measurements, eliminating manual error and device bias.